Transcutaneous Vagal Nerve Stimulation in Veterans with Posttraumatic Stress Disorder

Posttraumatic stress disorder (PTSD) is an important concern of the Veterans Administration,
associated with considerable morbidity, increased mental healthcare costs and loss of economic
productivity. A recent State of the Science conference convened by the Department of Defense on
Discovering Drug Targets for PTSD concluded that a decade of research costing millions of dollars
had yielded few new effective drug treatments for PTSD. In addition to limitations in efficacy,
pharmacological treatments can be limited by side effects or poor compliance, while
psychotherapeutic interventions may not be tolerated due to re-activation of traumatic memories.
Electrical treatments represent a new horizon in the treatment of PTSD and psychiatric disorders in
general. Earlier generations of electrical treatments were limited by the need for complicated
surgical and anesthetic procedures, high cost, and lack of reimbursement by insurance for
procedures or routine psychiatric follow-up. This prevented wide-spread implementation of these
treatments in psychiatry. New non-invasive transcutaneous cervical (neck) Vagal Nerve
Stimulation (tcVNS) devices that are economical and do not require surgical implantation
overcome these limitations of electrical treatments, as well as avoiding side effects or other
limitations to medication treatments for PTSD. VNS results in both enhancement of anterior
cingulate and reduction in insula responses to traumatic stress scripts as well as peripheral
cardiovascular / sympathetic and immune function, all of which indicate that they could act on
neurobiological and physiological systems that maintain symptoms of PTSD. Our preliminary data
shows that tcVNS (but not sham stimulation) when applied in conjunction with exposure to scripts
of specific traumatic memories blocks the effects of stress on increased peripheral vasoconstriction
and sympathetic tone as measured with direct cardiovascular measures (pre-ejection period, or
PEP) and reduces inflammatory markers (Interleukin-6) and insula response while enhancing
anterior cingulate function in PTSD. This project will explore the effects of tcVNS or sham
treatment on brain, cardiovascular / sympathetic and immune response to stress in veterans with
PTSD. Veterans will undergo exposure to traumatic script stress in conjunction with High
Resolution Positron Emission Tomography (HRPET) measurement of brain function and peripheral
cardiovascular /sympathetic function and immune biomarkers in blood. Veterans will then undergo
three months of twice daily treatment with tcVNS or sham stimulation followed by a repeat of these
measures. We hypothesize that tcVNS but not sham stimulation will result in a reduction in brain /
cardiovascular / sympathetic and immune response to stress in veterans with PTSD, as well as
symptoms of PTSD with long term treatment. This project will provide information about
mechanisms of tcVNS on the neurobiology and physiology of PTSD and ways in which it may
ameliorate symptoms of PTSD.

Public health relevance
Posttraumatic stress disorder (PTSD) is an important priority for the Veterans Administration, but treatments to date utilizing medications and / or psychotherapy have had limitations. Electrical treatments represent a new horizon in the treatment of PTSD and psychiatric disorders in general, and new non-invasive treatments avoid the high cost, and lack of reimbursement by insurance companies that limited wide-spread implementation of implanted stimulation devices. This project will look at a novel new possible treatment for PTSD that could represent a paradigm shift in this disorder called non-invasive transcutaneous cervical (neck) Vagal Nerve Stimulation (tcVNS) and how it affects brain and physiological responses to stress in veterans with PTSD as well as effects of long term treatment on PTSD symptoms.